RP2: Targeting Estrogen receptor and DNA damage repair disparities in African American and Hispanic/Latino breast cancer using Patient-Derived Breast Cancer Xenografts

Project Summary Background African American and Hispanic/Latino breast cancer patients are underrepresented in experimental models of breast cancer, as well as in clinical trials investigating new therapeutics. This oversight contributes to poor clinical outcomes observed for these minority ethnic groups across all types of breast cancer. This has generated a critical unmet need to identify experimental models that better represent these ethnic subsets in order to design clinical trials that are aimed to serve these populations. Objective/Hypothesis The objective of this study is to characterize the genome, transcriptome and kinome of 100 breast cancer PDX lines, >70% of which are derived from patients of African American or Hispanic/Latino ethnicity. By understanding fundamental cancer pathways specific to these minority groups this study will delineate efficacy of pre-­existing, CTEP-­approved therapies in minority ethnicities. Specific Aims Aim 1: Systematically characterize estrogen receptor (ER) signaling and response to endocrine treatment in PDX lines derived from AA and Hispanic breast cancer patients. Aim 2: Characterize DNA repair profiles of ER+ and triple negative PDX lines across ethnic groups. Aim 3: Generate -­omics? based network profiles specific for Hispanic, AA and CA PDXs. Study Design In Aim 1, global ER signaling pathways will be characterized across 30 PDXs derived from AA and Hispanic breast cancer patients by generating and analyzing whole exome sequence and RNA-­seq data from PDX tumors grown in the absence of estrogen. Growth response to estrogen deprivation and/or fulvestrant treatment of PDXs from these minority populations will also be tested. In Aim 2, differences in DNA repair defects, beyond BRCA1/2 mutations, will be characterized across 28 ER+ and 72 triple negative PDX lines derived from CA, AA and Hispanic breast cancer patients, with more than 70% of the lines being from minority populations. Based on differences in DNA repair defects, use of CDK4/6 inhibitors or PARP inhibitors in PDXs from AA/Hispanic patients will be tested in vivo. In Aim 3, an unbiased 10-­KiP assay will be used to characterize active kinomes of >100 PDX lines using 10 pharmacological kinase inhibitors covalently linked to sepharose beads. The top three pharmacological hypotheses generated by this assay will be tested in three ER+ and three triple negative PDX lines each from AA and Hispanic patients in vivo. Impact The results of this study will generate strong and comprehensive preclinical rationale to design clinical trials directed at finding better therapeutic solutions for minority populations, a long-­awaited development in breast cancer. Moreover, the characterization of >70 PDX lines derived from minority populations at the DNA, RNA and protein level will lay a foundation from which underlying molecular differences in breast cancer biology and outcomes based on race and ethnicity can be better studied.